Regulation of adrenal development and function by the mother's skeleton

PROJECT SUMMARY
The overall goal of this Application is to improve our understanding of the genetic and molecular control of
adrenal gland homeostasis by studying how osteocalcin originating from maternal skeleton, affects adrenal
growth and steroidogenesis of the offspring during development and after birth. Specifically we intend to 1]
Establish that maternal Ocn is necessary for proper adrenal gland development and function. We will also 2]
Establish genetically and in vivo that osteocalcin favors adrenal gland growth and steroidogenesis by signalling
directly in the adrenal cortices through its receptor Gpr158. A third purpose of this application is to determine
with precision the temporal course of osteocalcin’s effect on the adrenal gland development/function and
investigate how maternal osteocalcin affects this process in the offspring. We will use mouse genetic,
molecular and biochemical assays to investigate the molecular bases of the cross-talk between bone and the
adrenal gland through osteocalcin in the regulation of adrenal steroid production. Together, this application will
significantly advance our understanding of adrenal development and physiology in bony vertebrates by
describing a novel regulation of adrenal gland development and steroidogenesis, which originates from the
mother and is biologically relevant since its absence can be lethal.

Public health relevance
PROJECT NARRATIVE This application aims at demonstrating that adrenal development and lifelong synthesis of glucocorticoid and mineralocorticoid hormones in the offspring is determined in part by a maternal influence in bony vertebrates. This application will advance our understanding of vertebrate endocrinology by focusing on the novel regulation of adrenal steroidogenesis by the mother’s skeleton. This project will determine genetically, and in vivo, all aspects of this regulation during development and after birth.